EFFECT OF DIETARY FIBER IN PATIENTS WITH NIDDM

The primary aim of this investigation is to study the effect of total dietary fiber on glucose and lipid metabolism in patients with non-insulin dependent diabetes mellitus (NIDDM). In addition, effect of dietary fiber on intestinal lipid absorption of calcium, as well as, other minerals will be studied. Soluble fibers may have a cholesterol lowering effect, decreasing the risk of atherosclerosis and cardiovascular disease, as well as, improving glycemic control.